Drug Development Core Shared Resource

PROJECT SUMMARY / ABSTRACT
The mission of the Drug Development Core (DDC) is to make state-of-the-art drug development accessible
and affordable to UWCCC members. Development of innovative therapies is a priority area of research in the
UWCCC Strategic Plan, and drug development requires specialized expertise in synthetic, computational, and
analytical chemistry. The overarching scientific discipline in the DDC is medicinal chemistry in its broadest
sense. DDC offers compound discovery by high throughput screening (HTS); computational chemistry for in
silico virtual screening and modeling; chemical informatics to identify and prioritize compounds; chemical
synthesis of potent, selective, and pharmacologically viable compounds; and analytical chemistry to support
UWCCC clinical trials with pharmacokinetic (PK) and pharmacodynamic (PD) assays. Aim 1 is to advance
UWCCC member drug development research by providing broad medicinal chemistry expertise and
infrastructure encompassing discovery, synthetic chemistry, computational chemistry, analytical chemistry, and
pharmacology of chemoprevention and anticancer agents. DDC staff advise UWCCC members in all aspects
of experimental design and data interpretation. The highly-skilled and experienced staff are experts in the use
of state-of-the-art equipment for microwave-facilitated organic synthesis, analytical and preparative HPLC,
mass spectrometry, combi-flash chromatography, tip-less and tip-based liquid handling robotics, assay
quantification in 96 through 1536-well plate readers, and high throughput computing. Aim 2 is to support
clinical trials conducted at UWCCC by providing analytical chemistry expertise needed to evaluate the
pharmacokinetic and pharmacodynamic properties of study drugs and to provide patient sample storage with
robust and secure database documentation of all samples. DDC staff are tightly coordinated with the clinical
trial enterprise at UWCCC including participation in the Cancer Therapy Discovery and Development (CTD2)
group and the Disease Oriented Teams to support UWCCC members with assays for drug concentrations and
biomarkers on any clinical substrate and storage of study samples from clinical trials. In the current funding
period, the core provided support for 394 UWCCC studies. Aim 3 is to train UWCCC members, their staff, and
students in drug development processes and the productive application of state-of-the-art, well-maintained
equipment to their specific research goals and provide 24/7 access to this drug development focused
infrastructure. Impact on UWCCC: The DDC has supported the research of 128 unique UWCCC members
during the current funding cycle and is well-staffed and equipped to meet the future drug development needs of
UWCCC members. Continued support from the CCSG will enable highly experienced DDC staff scientists to
invest time and expertise in consulting with UWCCC members on future projects and on advancing current
promising molecules along the development pathway to the clinic.